1/8: INIA Stress and Chronic Alcohol Interactions: Role of Dynorphin/KOR and Oxytocin Systems in Stress-Enhanced Alcohol Drinking, Relapse, and Impaired Behavioral Flexibility

PROJECT SUMMARY
Stress is known to be a significant factor in triggering relapse, promoting heavy alcohol (ethanol) consumption,
and producing adaptations that reduce behavioral flexibility, thereby compromising control over alcohol drinking
and elevating susceptibility to relapse. Unfortunately, mechanisms and neurocircuitry underlying the complex
interaction between stress and alcohol drinking are not well understood. As part of the INIAstress Consortium,
we developed a mouse model in which repeated brief forced swim stress (FSS) exposure interacts with chronic
intermittent ethanol (CIE) exposure to selectively enhance alcohol drinking in dependent (CIE-exposed) mice.
During the current funding period we established a role for the pro-stress neuropeptide dynorphin/kappa opioid
receptor (DYN/KOR) system in stress-enhanced alcohol drinking. At the same time, we used operant
conditioning procedures to demonstrate that the anti-stress neuropeptide oxytocin (OT) reduced alcohol self-
administration and stress-induced relapse-like behavior. This research project focuses on the role of DYN/KOR
and OT systems within stress-relevant circuits in models demonstrating the ability of stress to interact with
chronic alcohol in promoting escalation of alcohol drinking, enhanced relapse-like behavior, and impaired
behavioral flexibility. The project will employ two stressors (forced swim stress (FSS) and predator odor (TMT)
exposure), two models of stress-alcohol interactions (CIE-FSS Drinking and stress (TMT)-induced operant
alcohol relapse seeking/drinking), and two measures of behavioral (in)flexibility (alcohol-biased choice behavior
and persistence of alcohol drinking despite aversion). Building on our previous work demonstrating an important
role for DYN/KOR activity in the central amygdala (CeA) and pilot data showing strong DYN input to the CeA
from the insular cortex (a stress and alcohol sensitive cortical area), studies will examine the role of DYN/KOR
signaling in insular cortical (IC) projections to the CeA (IC-CeADYN pathway). Other pilot data suggest that
the stress-buffering effects of OT may be mediated by signaling in the CeA. Thus, studies will examine OT
activity in hypothalamic (PVN) projections to the CeA (PVN-CeAOT pathway). Further, studies will examine
the potential unique interactive effects of the DYN/KOR and OT systems in the PVN on behavioral
consequences of stress-alcohol interactions. The general experimental strategy will entail utilizing transgenic
mice and pharmacological, chemogenetic, and CRISPR/Cas9 approaches to target manipulation of these
neuropeptides in specific neurons within these specific neurocircuits. Collectively, these studies focus on
adaptations in pro-stress (DYN/KOR) and anti-stress (OT) systems within stress-relevant neurocircuits using
different stressors and different drinking models, thereby directly interfacing with the overall thematic framework
of the consortium. The ultimate goal is to gain new knowledge that will inform development of more effective
interventions for treating stress-related excessive alcohol drinking and relapse.

Public health relevance
RELEVANCE Alcohol use disorder is a major health concern that exacts significant social and economic burden on the United States, and stress significantly contributes to this problem. This research project aims to enhance our understanding about brain mechanisms and circuits that underlie the ability of stress to further increase alcohol drinking, trigger relapse, and exacerbate impaired ability to engage behavioral flexibility that would serve to dampen stress-alcohol interactions. The overall goal is to use this knowledge to facilitate development of new and more effective interventions for treating stress-related excessive alcohol drinking, and alcohol use disorder in general.